Sensory recruitment by working memory: neuronal basis and neural circuitry

Working memory maintenance is fundamental for the orderly pursuit of goals in the
face of irrelevant, distracting stimuli. Both prefrontal and visual areas are thought to
contribute to the maintenance of items in working memory, but the exact nature of the
interaction between these areas has yet to be causally examined. This proposal
combines neurophysiological recordings of single unit activity and local field potentials
with pharmacological manipulations of the prefrontal cortex, to determine its contribution
to memory-driven changes in neural activity and synchrony within visual areas. Local
field potentials allow the examination of oscillatory signatures and phase locking, and
their contribution to the strength of the visual representation. Such changes in oscillatory
power and the timing of spikes relative to ongoing oscillations have recently been shown
to reflect the content of working memory. Experiments in this proposal will 1) causally
test whether prefrontal cortex drives these oscillations in posterior areas, 2) construct a
model and test its predictions for how this top-down signal drives oscillatory changes, 3)
determine how these changes alter the representation of visual stimuli presented during
working memory maintenance, and 4) establish the relationship of these changes in
oscillatory power and spike timing to the stimulus’ ability to impact behavior. This
fundamental understanding of the neural mechanisms contributing to working memory
maintenance will in turn provide insight into the basis for working memory impairments in
disorders such as schizophrenia, attention deficit hyperactivity disorder, and Parkinson’s
disease.

Public health relevance
Maintaining working memory is crucial for performing everyday tasks, but the interactions between prefrontal and visual areas that underlie this maintenance are still being investigated. The proposed series of combined electrophysiological recordings of single-neuron activity and local field potentials, along with pharmacological manipulations, will elucidate the role of prefrontal cortex in driving changes in neural activity and synchrony within visual areas during working memory, and the contribution of these changes to driving behavior. This will help illuminate the basis for working memory impairments in disorders such as schizophrenia, attention deficit hyperactivity disorder, and Parkinson’s disease.